Identifying and Distinguishing Early indicators of Autism in Latino children (IDEAL)

Project Summary/Abstract
Current prevalence rates from the Centers for Disease Control and Prevention indicate that 1 in 36 children
have an autism spectrum disorder (autism). When considering the United States population, we find that
approximately 26% of children are Latino. However, research on autism does not currently reflect the ethnic
diversity of the population. Thus, recommendations and best practice guidelines for screening, diagnosis, and
therapeutic support for autism may not reflect the needs of Latino children with autism. This results in
significant disparities in identifying Latino children with autism, which can have long-lasting effects on
developmental outcomes, well-being, and quality of life for Latino children with autism and their families.
Underlying many of these disparities is the linguistic diversity observed in many Latino families and the limited
knowledge about how language, communication skills, and autism symptoms manifest in early childhood.
However, much of the autism research limits participation to English speakers, resulting in less knowledge
about autism among non-English-speaking communities. Additional challenges arise when considering that
bilingual (English/Spanish) environments may be more common among Latino children, and by extension,
Latino children with autism. The current project will identify and measure the early developmental trajectories
of language and communication skills of Latino children and assess and characterize the emergence of autism
symptoms among Latino children with a high and low likelihood of autism. The proposed study's aims are to 1)
identify and distinguish Latino children's language and communication profiles through a cross-sectional
analysis; 2) assess and characterize the developmental trajectories of language and communication skills
(English, Spanish) in Latino children between 1 and 5 years of age, and 3) assess and characterize the
developmental trajectories of autism symptoms between 1 and 5 years of age in Latino children. We will use a
cohort sequential design and multiple methods to capture comprehensive profiles of language and
communication skills and autism symptoms to measure early development between 1 and 5 years of age
among Latino children. The results of this study will help identify the developmental points when language and
communication diverge between Latino children with a high and low likelihood of autism. Furthermore, the
results will help clarify when and how autism symptoms can be distinguished between Latino children with a
high and low likelihood of autism. These recommendations can have long-lasting effects on addressing the
disparities Latino families of children with autism face in accessing culturally and linguistically informed
services.

Public health relevance
PROJECT NARRATIVE The proposed project will identify and distinguish the early indicators for autism among Latino children by characterizing the early developmental trajectories of language, communication, and autism symptomatology. Identifying early indicators is critical to ensure that Latino children are identified early and can benefit from early intervention services. The results of this project will inform clinical recommendations for early screening and identification of Latino children.